Chemical Biology of Nitroxyl (HNO)

the chemical biology of HNO, is to determine the pharmacological and possible endogenous production of this species in vivo. One of the challenges is to determine the role that HNO may have in the biochemistry of nitric oxide synthase (NOS). In addition, we have found that NH2OH may be an important precursor to HNO under oxidative conditions. This indicates that hydroxyamic acids such as chemotherapeutic drugs hydroxyurea and SAHA may mediate some effects through HNO. Here we have investigated a variety of HNO donors and method of generation in vivo. We have currently discover a specific marker for HNO and found that it can be detected in cells. Furhtermore, we have been able to determine protemic and genomic signature that differ from HNO and NO. These finding furhter support our hypothesis that these species have mutaully exclusive biology. We have current extended this project to better understand nitrosation and H2S as well as persulfides. It has been recognized that persulfides and H2S may have a critical role in numerous cancer and provides and important target.